Addressing Malnutrition in Transplant and Cellular Therapy Patients with Healthcare-Food Bank Partnerships

Inconsistent food availability (IFA) affects 17 million (12.8%) of American households. IFA is exacerbated in patients with complex medical conditions, and it is associated with worse health outcomes and increased healthcare utilization and costs. Strategies to address IFA such as home-delivered meals or food assistance programs like food banks/pantries/pharmacies may improve healthcare outcomes. However, home-delivered meals are associated with higher costs due to individualized delivery while food assistance programs have several challenges to participation. We propose to leverage the strengths of both those approaches in a novel partnership between cancer centers and food banks called Nutrition OUtReach In Systems of Healthcare (NOURISH), to directly deliver food to patients in clinic. Patients, caregivers, dietitians, social workers, nurses, physicians, food bank staff, and local partners will work together to determine medically tailored options for the patient population; food banks will oversee sourcing and preparing bags of food; and healthcare providers will distribute bags to patients in clinic after their appointments. Because NOURISH does not require patients to make an extra trip and bags are distributed discreetly to avoid stigma, it increases adoption; because food is handed out in clinic, it lowers costs. We propose to evaluate NOURISH in a multicenter randomized controlled trial in IFA patients with hematologic malignancies receiving transplant and cellular therapy (TCT). We chose this population for three reasons: (1) TCT patients are in great need as approximately 75% will relocate to live near a quaternary cancer center (QCC) for a month or more while receiving TCT, removing them from their normal sources of support; (2) TCT patients are more likely to experience malnutrition and other adverse outcomes, often struggling with nausea, anorexia, and other side effects that can be exacerbated by IFA; (3) TCT may be a model for sustaining care: while other Food is Medicine initiatives have shown economic benefits, because cost savings do not flow to healthcare systems, there is little incentive for implementation. In contrast, TCT is among the most expensive medical procedures, and healthcare systems are typically reimbursed through bundled payments. As a result, QCCs have an incentive to pursue strategies that may lower costs and improve outcomes. For example, many TCT patients with IFA will receive total parenteral nutrition, at significant cost. NOURISH may prevent malnutrition and the need for intravenous nutrition through much cheaper food assistance. The success of our randomized controlled trial will provide a compelling rationale for QCCs to continue to fund food banks in their communities, providing much-needed financial support to sustain these partnerships while improving access and outcomes for patients. Furthermore, positive experiences in TCT may lead to the expansion of these partnerships to the broader cancer population and beyond.
.

Public health relevance
We propose a novel partnership between medical clinics and food banks, called Nutrition OUtReach In Systems of Healthcare (NOURISH), to address lack of consistent access to food by directly delivering bags of food to patients in clinic. We will evaluate NOURISH in a multicenter randomized controlled trial in individuals with inconsistent access to food and hematologic malignancies receiving transplant and cellular therapy (TCT). We focus on this patient population because of their significant need – most relocate to a cancer center for their care, away from their home support network, and struggle with malnutrition, depression, and other adverse outcomes – and potential for long-term sustainability: bundled payments for TCT give health systems an incentive to support NOURISH and similar collaborations with food banks if we can demonstrate improved outcomes and lower healthcare costs.